Developing a Primary Care Intervention to Support Reproductive Decision-Making among Black and Latina Women of Reproductive Age with Type 2 Diabetes

Project Summary/Abstract
Candidate: The goal of this K01 Award is to support the training and research of Dr. Cassondra Marshall,
who's long-term goal is to advance reproductive and maternal health equity through the translation of evidence
into practice using tailored interventions that address the needs of racial/ethnic minority women with chronic
medical conditions. Her research has examined young women's contraceptive decision-making and has
explored the ways in which health care providers and systems can deliver patient-centered contraceptive care.
Research Plan: Women with diabetes prior to pregnancy have elevated rates of maternal and neonatal
morbidity and mortality. Type 2 diabetes is increasingly prevalent among women during their childbearing
years, disproportionately impacting Black and Latina women. To prevent maternal and infant health
complications, there is an urgent need for enhanced efforts to improve reproductive health outcomes among
reproductive-aged women with type 2 diabetes, particularly racial/ethnic minorities. However, there are
currently no evidence-based strategies to implement clinical guidelines for improving reproductive outcomes
among adult women with type 2 diabetes. Patient decision support tools in primary care represent a promising
implementation strategy. The research aims are: Aim 1: Elucidate reproductive decision-making processes and
reproductive health care preferences among Black and Latina women of reproductive age with type 2 diabetes,
using person-centered and structural competency frameworks. Aim 2: Adapt an existing patient decision
support intervention to support reproductive decision-making and reproductive health counseling delivery in
primary care to meet the needs of Black and Latina reproductive-aged women with type 2 diabetes. Aim 3:
Assess acceptability and feasibility of the adapted intervention among patients and providers and examine the
implementation context for the intervention. Career Development and Training Plan: The candidate's training
plan capitalizes on an interdisciplinary mentoring team with expertise in person-centered family planning care,
diabetes care, implementation science, and organizational research in primary care. Through coursework,
workshops, apprenticeships, and mentored research experiences, Dr. Marshall will receive training in Person-
Centered and Structurally Competent Reproductive Health Interventions, Advanced Mixed Methods,
Implementation Science and Stakeholder Engagement, and Designing and Implementing Trials in the Primary
Care Setting. UC Berkeley and close partners UCSF and Kaiser Permanente Northern California provide an
excellent research infrastructure and training environment for Dr. Marshall. Summary: The training and
research proposed in this application position Dr. Marshall to be competitive for R01 funding to support a
multisite effectiveness-implementation trial of the adapted intervention and facilitate her transition to
independence as a researcher.

Public health relevance
Project Narrative Type 2 diabetes is increasingly prevalent among women during their childbearing years and disproportionately impacts Black and Latina women. Type 2 diabetes increases the risk of maternal and neonatal morbidity and mortality, but there are currently no evidence-based strategies to implement clinical guidelines for improving reproductive outcomes among adult women with type 2 diabetes. The proposed research will advance our understanding of clinical and health system approaches to improving reproductive health outcomes and delivering reproductive health care to reproductive-aged Black and Latina women with type 2 diabetes, by: 1) elucidating their reproductive decision-making processes and reproductive health care preferences using person-centered and structural competency frameworks, 2) adapting an existing patient decision support intervention to support reproductive decision-making and reproductive health counseling delivery in primary care to meet the needs of this population, and 3) assessing acceptability and feasibility of the adapted intervention and examining the implementation context for the intervention.